Retrieval-Based Word Learning in Autism Spectrum Disorder

PROJECT SUMMARY/ABSTRACT
Many children with autism spectrum disorders (ASD) have word-learning difficulties, with particular
weaknesses in developing rich semantic representations over time that can be flexibly applied to new contexts.
This negatively impacts academic performance, functional independence, and quality of life. Despite this, there
are very few evidence-based intervention techniques that have been directly examined in children with ASD.
Within the psychological learning literature, there is a promising teaching technique that highlights not only the
input that individuals receive when learning but also opportunities to recall or produce newly taught information.
The retrieval of new information is not only important for the assessment of learning, but for learning itself. It is
believed that effortful retrieval practice (repeated spaced retrieval RSR) enhances encoding because retrieval
of new information prompts individuals to identify features of the word or concept that are necessary to
reconstruct the material, which leads to an enriched and potentially elaborated memory trace to support future
retrievals. Although retrieval practice studies have yielded robust learning effects in adults, its application to
child learning is in its infancy. Given the striking learning effects that have been documented in adults and
some emerging findings in children with developmental language disorder, retrieval practice has great potential
to enhance word learning in children with ASD. RSR holds promise for children with ASD because its use has
been found to facilitate not only learning of word form (corresponding to the sounds that comprise a word), but
also word meaning (corresponding to semantic features associated with the newly taught word), which is a
particular weakness in children with ASD. Also, RSR may be a key clinical approach to use with children with
ASD because it has been found to strengthen not only item-specific learning (e.g., labeling pictured referents
that were explicitly taught), but also to enable generalization (e.g., correctly applying newly taught adjectives to
novel referents or labels to different referents of the same kind). Thus, Study 1 will assess whether RSR of
newly taught labels (nouns) results in more robust learning of word form and meaning of nouns relative to a
learning schedule that has the same amount of study without retrieval (repeated study, RS). Also, Study 1 will
examine whether RSR promotes generalization in children with ASD in a task that tests children's extension of
labels to referents that are similar to but distinct from the referents that were explicitly taught. Study 2 will
assess whether RSR facilitates adjective learning, which allows for more stringent analysis of broader
language learning and generalization. Across Studies 1 and 2, addressing specific aim 3, we will examine
generalization using pictures of similar referents (Study 1) or similar attributes on novel referents (Study 2).
Lastly, we will assess whether ASD severity moderates the RSR effect, after controlling for cognitive and
language abilities, addressing specific aim 4. Findings from this study will inform our theoretical understanding
of language acquisition in children with ASD and will lead to clear clinical implications.

Public health relevance
PROJECT NARRATIVE The goal of this research is to evaluate whether repeated spaced retrieval practice promotes word learning to a greater extent than repeated study without retrieval prompts in children with autism spectrum disorders (ASD). This study will assess multiple aspects of word learning including word form (phonological information for each novel word), word meaning (semantic information associated with each novel word), and generalization of newly taught words. This comprehensive assessment of word learning is particularly important for the ASD population because they have deficits in word learning, with particular challenges with semantic learning and generalization; therefore, identification of effective teaching strategies (i.e., retrieval practice) will have important implications for theories of language learning in children with ASD and will yield meaningful clinical/educational implications.